TAUROURSO DEOXYCHOLIC ACID IN CYSTIC FIBROSIS LIVER DISEASE

The two specific aims of this multicenter are to a) determine the optimum dose of TUCDA required to achieve maximal bioavailability, defined by biliary enrichment in TUDCA, and 2) perform a double blind crossover study of TUDCA and UDCA in patients with CF associated liver disease comparing: biliary bile acid composition and effect on serum biochemistries in vitamin E status and fecal fat excretion.